U-RISE at the University of the Virgin Islands

Abstract
The University of the Virgin Islands, an undergraduate HBCU serving a unique population, proposes a
continuously improving U-RISE program for students in all the relevant biomedical and behavioral disciplines
across both its St. Thomas and St. Croix campuses. The overall mission of this program is to provide training
experiences that will foster excitement about scientific careers, develop the trainees' identities as biomedical
researchers, and build skills needed for success. The program’s overarching purpose is to prepare UVI
undergraduate students to obtain PhDs and engage in biomedical research careers. Through a
comprehensive program of mentoring, research experiences, conferences, workshops, and seminars, U-
RISE at UVI will provide trainees with biomedical research training and a clear pathway to obtaining their
PhD. The goals are that the program will: (1) provide students with a rigorous curriculum that develops both
verbal and quantitative skills, (2) provide research training opportunities through extramural summer research
experiences and academic year experiences that prepare trainees to produce high quality scientific work, (3)
provide students with a clearly articulated career pathway for admission to highly selective research
universities and a structure for success, (4) develop strong partnerships with research-intensive institutions,
including T32 funded programs, (5) develop strong professional networks for UVI students and faculty, and
(6) provide URISE students with effective mentoring on multiple levels (including near-peer mentors,
academic mentors, and research mentors). To achieve these goals, some of the program’s measurable
objectives include: (1) 100% of URISE trainees will graduate, (2) at least 30% of the students producing
exceptionally high-quality work (for example, having an abstract accepted at disciplinary meeting), (3)
mentors and mentees will report spending productive time together each semester, (4) mentors and mentees
will produce products from their work, such as conference presentations and published journal articles (5)
95% of URISE students apply to doctoral programs by November 30 of their senior year, (6) 65% of trainees
will enroll in doctoral programs within three years of graduation, and (7) 60% of trainees will complete higher
degree programs. These objectives will be accomplished with a program that builds on past success and
includes new curricular modules and workshops, extramural research, presentations at conferences, visiting
scientists, and a network of support for trainees. U-RISE at UVI has designed a program that combines highly
competitive partners and exciting new initiatives at UVI to continue to improve its historical record of
producing minority PhDs.

Public health relevance
Project Narrative This project is relevant to public health because it will produce a diverse group of rigorously trained, motivated undergraduate students who will be competitive for highly selective doctoral programs and, as biomedical researchers, contribute to the quality and diversity of the scientific workforce. These talented University of the Virgin Islands students will be future leaders in addressing the health research needs of the Nation. They will contribute a unique perspective because of their cultural and socio-economic backgrounds; these perspectives will be important not only to addressing health disparities but also to breakthroughs across the scope of biomedical and behavioral sciences.